Deciphering Central Nervous System Autoimmunity in Down Syndrome

PROJECT SUMMARY
Down syndrome (DS), caused by the triplication of chromosome 21, is associated with an increased
prevalence of autoimmune diseases and neurological dysfunction, potentially driven by chronic inflammation
resulting from the overexpression of four interferon receptors (IFNRs). Human chromosome 21 carries four of
the six IFNR genes, and their triplication in DS results in significant immune dysregulation and chronic
inflammation, characterized by elevated levels of various pro-inflammatory cytokines. This persistent systemic
inflammation leads to an autoimmune-prone state, with over 60% of adults with DS experiencing one or more
autoimmune diseases. Systemic inflammation and increased cytokine levels may also compromise the integrity
of central nervous system (CNS) tight junctions (TJs) — essential structures that form seals between cells in the
brain’s protective barriers, preventing harmful substances and immune cells from infiltrating the brain. When
these TJs are disrupted, autoantibodies and immune cells can penetrate the CNS, contributing to neurological
phenotypes. Despite substantial evidence of CNS TJ dysfunction in DS, including significant correlations
between peripheral autoantibodies and neurological phenotypes, as well as elevated levels of a TJ-degrading
protein, this critical aspect of neurological health remains underexplored in individuals with DS. This study seeks
to uncover the mechanisms by which IFNR triplication induces CNS autoimmunity in DS through a cross-species
investigation. By utilizing human samples and mouse models, this project will examine how IFNR triplication
contributes to an autoimmune-prone state, CNS TJ dysfunction, and ultimately, CNS autoimmunity. In Aim 1,
autoimmune processes affecting the CNS in DS will be identified. Aim 2 will complete a cross-species
investigation of CNS TJ integrity in DS. Finally, in Aim 3, mechanisms of CNS autoimmunity will be investigated
using a mouse model of DS. The overall hypothesis of this proposal is that systemic inflammation caused by
IFNR triplication in DS leads to an autoimmune-prone state and CNS tight junction dysfunction,
ultimately resulting in CNS autoimmunity. By elucidating these mechanisms, this study aims to guide
therapeutic strategies that stabilize CNS barriers, mitigate immune cell infiltration, and improve neurological
outcomes for individuals with DS. Additionally, this research has broader implications, as it sheds light on CNS
TJ dysfunction and the effects of dysregulated inflammatory pathways, offering valuable insights into other
inflammatory and autoimmune-driven neurological conditions beyond DS.

Public health relevance
PROJECT NARRATIVE Down syndrome is associated with an increased prevalence of autoimmune disorders and neurological dysfunction, potentially driven by chronic inflammation resulting from the overexpression of certain immune receptors. This inflammation contributes to an autoimmune-prone state and may weaken barriers protecting the brain, allowing harmful substances and immune cells to enter. The goal of this project is to study how this inflammation affects the immune system and the brain's defenses in Down syndrome, with the hope of developing treatments to improve brain health and providing insights that could help other neurological conditions linked to inflammation or immune system dysfunction.